Delirium, Alzheimer's Disease Biomarkers, and Long-Term Cognitive Decline

ABSTRACT
While delirium and dementia are the most common causes of cognitive impairment in older adults, their
interrelationship is complex and poorly understood. Many questions remain unresolved: Does pre-existing
Alzheimer's disease (AD) pathology increase vulnerability to delirium? Does delirium increase cognitive decline
in those with AD pathology? Do AD pathology and delirium interact to promote cognitive decline or dementia?
Project 1 will investigate the inter-relationship of delirium and long-term cognitive decline (LTCD) with
molecular biomarkers of AD pathology according to 3 general components of the new "ATN" (Amyloid−β [Aβ],
Tau, Neurodegeneration) descriptive classification scheme for AD biomarkers. We propose the following
specific aims: (1) to examine the relationship between baseline cerebrospinal fluid (CSF) AD biomarkers (CSF
Aβ42, total tau [t-tau], phospho-tau tau/Aβ42 ratios, and neurofilament light [NFL]), sampled prior to spinal
anesthesia, and development of post-operative delirium and cognitive decline over 18-36 months in a new
cohort of 400 older persons undergoing joint replacement surgery (SAGES II); (2) to evaluate associations of
history of delirium and CSF AD biomarkers (sampled near 4 year follow-up) with LTCD (over a minimum of 8
years) in a probability sample from SAGES I (N=128): 64 patients who developed delirium during the initial
hospitalization and 64 who did not develop delirium during the initial or subsequent hospitalizations; and (3)
after correlating CSF and plasma levels of novel SiMoA assays of t-tau and NFL obtained at follow-up in the
SAGES I probability sample (N=128), to examine the relationship of pre-operative levels of these markers
obtained from stored plasma with delirium incidence/severity and LTCD following delirium. We have conducted
detailed pilot work ensuring the feasibility of the proposed work, including assuring adequate numbers of
available patients and their willingness to participate, and verifying feasibility and tolerability of all study
procedures. We have demonstrated adequate statistical power to examine our aims. The success of the
proposed work is further assured by a highly skilled interdisciplinary team of study investigators who have been
working together for 2-11 years, by the demonstrated attainment of all of the previous aims, and by enrolling a
large, complex cohort of over 560 surgical patients along with 119 non-surgical controls during the initial cycle.
This project will probe whether fluid biomarkers identify patients who are more vulnerable to delirium, and
are most likely to have cognitive decline following delirium. By probing the relationship of delirium and AD
biomarkers, we will be well positioned to advance our mechanistic understanding and to develop more
effective intervention strategies to forestall LTCD associated with delirium and AD. Moreover, this study may
lay the groundwork for identification of potential plasma biomarkers for AD and related dementias (ADRD). If
our hypotheses are confirmed, this study will offer compelling support for the importance of prevention of
delirium to forestall the progression of cognitive decline in AD/ADRD.